Coordinating Center for Primate Aging Research

SUMMARY
The Tulane National Primate Research Center (TNPRC), California National Primate Research Center
(CNPRC), and Baylor College of Medicine (BCM) present a unique combination of resources and expertise to
support and enhance “studies…of primate species life span differences, and mechanisms that may mediate
such relationships,” per RFA-AG-24-019. This R61/R33 application proposes a newly instantiated Coordinating
Center for Primate Aging Research (CCPAR) jointly led by these institutions. The CCPAR will coordinate the
work of a broad array of specialists across gerosciences and facilitate integration of data from R01s across
sites, endpoints, approaches to measurement, and species. Both NPRCs have well-established NIA-supported
colonies of aged rhesus macaques and core scientists engaged in aging-related research. These two NPRCs,
along with the broader NIH-funded NPRC Consortium and BCM, are uniquely qualified to successfully lead the
proposed CCPAR. The CCPAR will build a community of transdisciplinary nonhuman primate (NHP) aging
researchers, develop novel resources to facilitate rigorous studies and data harmonization, and disseminate
resources to the broader community through data sharing and public-facing communication. There will be a
focus on training, best practices, communication, and outreach within the Coordinating Center that forms the
basis of broadly distributed “white papers.” There will be a commitment to enhancing the quality of data on
longevity and health span, as well as the availability of such data through dedicated IT experts, databases, and
websites. The overall goal is to increase the harmonization and integration of existing data while putting
systems in place to enhance data sharing for future studies. The CCPAR has the expertise necessary to assist
in the design of robust methods, interpret multiple types of data, and link genetic data to cellular and behavioral
data as well as key environmental events that influence aging. We will pursue the following three Specific
Aims, with the first two pursued in the R61 and R33 phases, and the third primarily pursued in the R33 phase:
Aim 1. Enhance the quality and synergy of projects supported through RFA-AG-24-019 and facilitate the public
accessibility of their results; Aim 2. Identify promising directions for future research on determinants of species
differences in human and nonhuman primate life spans and age-related outcomes through activities that
engage researchers from pertinent fields; and Aim 3. Enhance the quality, public availability, and
interoperability of data sources needed to design and implement research on determinants of species
differences in human and nonhuman primate life spans and age-related outcomes.

Public health relevance
NARRATIVE This application proposes a newly instantiated Coordinating Center for Primate Aging Research (CCPAR) to coordinate the work of a broad array of specialists across gerosciences and facilitate integration of data from NIA-funded research programs across sites, endpoints, approaches to measurement, and species. A major focus of the supported grants will be comparative studies across multiple nonhuman primate (NHP) species with the goal of illuminating determinants of lifespan and healthspan in humans. This proposal is aimed at coordinating multi-species data that identify intrinsic and extrinsic factors of age resilience that which could be leveraged to slow biological aging in humans and lead individuals to live longer, better lives with fewer age-associated comorbidities.